Multifunctional morphogens: patterning precision and mesoderm migration

PROJECT SUMMARY
Across development, a relatively small set of cell signaling pathways simultaneously controls many cell behaviors
including proliferation, differentiation, and migration. How cells process signaling information to perform multiple
functions and what limits their precision remains poorly understood. Complex pathway interactions generate
dynamic signaling patterns that are difficult to disentangle in vivo. Moreover, many details of these interactions
are species specific so that findings in model organisms cannot be simply translated to human. Our overall goal
is to uncover how combinatorial cell signaling dynamics orchestrate development and determine what limits their
precision. Our approach combines application of experimental and theoretical methods to stem cell models of
human development. We previously created an experimental and computational pipeline to track cell signaling
history and link it to fate in individual cells. We also developed an iterative staining method to take snapshots of
many signals and fate markers simultaneously, and a theoretical framework to interpret this data. Moreover, we
implemented a range of tools to study FGF signaling in human pluripotent stem cells. Finally, we established a
highly reproducible model for human mesoderm migration. We used these methodological advances to provide
new insight into both fundamental aspects of developmental signaling and specifics of human development. For
example, we showed it is the total (BMP) signaling over time that controls differentiation to amnion-like cells, not
the absolute level or duration as was previously thought. We also discovered how the relative timing of signals
controls differentiation of primordial germ cell-like cells, which are of great interest for understanding and treating
infertility, and we leveraged our insights to double the efficiency with which these can be derived in vitro. Building
on our previous work, here we propose to address two unresolved questions: 1) How does cell signaling history
control the precision of final cell fate and signaling patterns? 2) Which cues guide human mesoderm migration
and how are they linked to fate? Defects in differentiation and migration during early development are linked to
congenital birth defects and infertility, while imprecision of in vitro development limits applications of stem cell
technology. This research will advance our understanding of cell signaling in developmental biology and disease
with applications to stem cell technology.

Public health relevance
PROJECT NARRATIVE (public health relevance statement) Defects in cell signaling control of differentiation and migration during early embryogenesis cause developmental disorders and infertility, while imprecision of these processes in vitro is a major obstacle for stem cell technologies to improve human health. This research will use innovative experimental and theoretical approaches to advance our understanding of the fundamental mechanisms by which cell signaling controls differentiation and migration in human stem cells.